YAP/TAZ Regulation of Extracellular Matrix Homeostasis

ABSTRACT:
The major goal of this grant application is to determine the molecular mechanisms by which YAP/TAZ regulate age-related
skin dermal extracellular matrix (ECM) homeostasis.
In human skin, dermal fibroblasts are responsible for the production, organization, and homeostasis of the collagen-rich
dermal ECM, which comprises the bulk of the skin. In young skin, direct attachment to intact collagen fibrils allows
fibroblasts to achieve a spread architecture, through mechanical forces generated by the assembly of the cytoskeleton.
In this state, the YAP/TAZ pathway is active, which maintains a youthful anabolic phenotype with net ECM production. In
aged skin, fragmented collagen fibrils do not support fibroblast attachment, resulting in reduced mechanical force/stretching
and a decline in YAP/TAZ function. In this state, fibroblasts display an aged catabolic phenotype, with net ECM degradation,
which is self-perpetuating and creates a dermal microenvironment milieu that promotes the pathogenesis of many age-
related skin diseases.
We propose to investigate the hypothesis that the YAP/TAZ mechano-sensing signaling pathway in dermal fibroblasts is a
critical regulator of age-related dermal ECM homeostasis. This data-driven hypothesis encompasses the key concept that
dermal ECM homeostasis is governed by the adaptation of fibroblasts to the surrounding ECM microenvironment, rather
than cell‐autonomous factors. Thus, we view dermal ECM homeostasis as involving “outside‐in adaptation” of dermal
fibroblasts to the age‐related state of the dermal ECM, in which fibroblasts are embedded, and that this adaptation is
critically regulated by YAP/TAZ.
To test the above hypothesis, we have recently generated two complementary genetically modified mouse models: 1)
conditional knockout of Yap/Taz in dermal fibroblasts, which results in striking impairment of both neonatal dermal ECM
maturation and signiﬁcantly accelerated chronological dermal ECM aging; 2) humanized mouse model of dermal aging
driven by expression of collage-degrading matrix metalloproteinase-1 in dermal fibroblasts. Importantly, this model
displays physiological inactivation of YAP/TAZ in response to ECM degradation.
Following Specific aims are proposed to test the stated hypothesis:
AIM 1: DETERMINE THE MOLECULAR MECHANISMS BY WHICH YAP/TAZ MEDIATES DERMAL ECM HOMEOSTASIS
DURING EARLY POSTNATAL LIFE AND CHRONOLOGICAL AGING
AIM 2: DETERMINE THE IMPACT OF RESTORATION OF YAP/TAZ FUNCTION ON DERMAL ECM HOMEOSTASIS
AIM 3: INVESTIGATE MECHANISMS BY WHICH AGE-RELATED FUNCTIONAL DECLINE OF YAP/TAZ IS MEDIATED BY
FIBROBLASTS “OUTSIDE-IN ADAPTION”

Public health relevance
Project Narrative The major goal of this grant application is to determine the molecular mechanisms by which the transcriptional co-activators YAP/TAZ control age-related skin dermal extracellular matrix (ECM) homeostasis. In this application, we will test the novel hypothesis that dermal ECM homeostasis is governed by the adaptation of fibroblasts to the state of the surrounding ECM microenvironment and that this “outside-in adaptation” is critically regulated by YAP/TAZ.